Studying the ERK phosphorylation of the BCAT protein

The cytosolic and mitochondrial isoforms of human branched chain aminotransferase (hBCATc and hBCATm,
respectively) catalyze the transamination of the branched chain amino acids (BCAA) to their respective α-keto
acids and glutamate. In addition, we recently found that hBCAT is phosphorylated by the canonical mitogen-
activated protein kinase (MAPK) family member, extracellular regulated kinase 1/2 (ERK1/2). Our research
team has shown direct evidence that ERK1/2 protein interacts with hBCATc in vitro and in breast cancer cells.
More specifically, we found in breast cancer cells the overexpression of BCAT1 (gene encoding hBCATc)
resulted in decreased levels of ERK1/2 activation/phosphorylation, and our in vitro experiments showed
activated/phosphorylated ERK1/2 phosphorylates hBCATc regulated by the redox center of hBCAT. Together,
the physiological implications of these observations are considerable to better understand the cellular and
molecular mechanisms of how hBCATc interacts with ERK1/2. In this proposal we will focus on the protein-
protein interaction of ERK1/2-mediated phosphorylation of the hBCATc. Based on preliminary studies, we
hypothesize that the redox center regulated phosphorylation of hBCATc by ERK1/2 signals this metabolic
protein to play additional functional roles in the cell, with the redox center of hBCAT playing an important role in
protein-protein interactions between hBCAT and ERK1/2. We hypothesize that hBCAT is differentially
phosphorylated by various kinases, which causes a conformational change of hBCAT that potentially confers
p-hBCAT with new functions. In the proposed project, we will study the regulatory effects of phosphorylation of
hBCAT by ERK1/2 using complementary biochemical and biophysical strategies, including kinetics analysis,
mass spectrometry and X-ray crystallography. Likewise, redox regulation of ERK1/2 is also a theme to be
developed in this project. Together, these experiments are expected to provide a comprehensive basis for
understanding the mechanism of the redox-regulated phosphorylation of BCAT by ERK1/2, and the structural
effects of phosphorylation on hBCAT. Moreover, these studies will establish a workflow to examine various
hBCAT-kinase interactions and help us further study the phosphorylation-mediated conformational changes of
hBCAT by other kinases that will help us to better understand the functional consequences of intracellular
phosphorylation of hBCAT. This project will provide for the first-time unique insights into the molecular
mechanisms underlying the redox regulation of hBCAT-ERK1/2 interactions, which will fundamentally inform its
role in disease conditions such as breast cancer and Alzheimer’s disease.

Public health relevance
The proposed research will advance our understanding of the molecular mechanisms underlying the interac- tion between the cytosolic human branched chain aminotransferase (hBCATc) and extracellular-regulated ki- nase 1/2 (ERK1/2) via redox- and phosphorylation-dependent mechanisms. Ultimately, these studies will contribute to our understanding of key signaling events involved in the regulation of important cellular pro- cesses, such as protein synthesis, cell proliferation and apoptosis, regulated by hBCAT and ERK1/2 in the context of breast cancer.